Mechanism of developmental toxicity of Bisphenol-A

DESCRIPTION (provided by applicant): Developmental exposure to bisphenol-A (BPA) at doses within the range of human exposure causes a complex array of adverse effects in animals. These outcomes are also known to be present in human populations and the rise in their occurrence coincides with the massive use of BPA and other endocrine disrupting chemicals in consumer goods. The main hormonal activity of BPA is as an estrogen mimic. Exposure to estrogens throughout a woman's life, including the period of fetal development, is considered a main risk factor for breast cancer. Developmental exposure to BPA altered mammary gland morphogenesis in rodents during the period of exposure and led to the development of pre-neoplastic and neoplastic lesions appearing in adulthood. The goal of this proposal is to identify the molecular, cellular and morphogenetic mechanisms underlying BPA-driven altered mammogenesis that predisposes to neoplastic transformation. To achieve this goal, we will use innovative tools such as a fetal mammary gland explant culture model that allows testing for direct effects of hormones and real-time observation of organogenesis. The Specific Aims of this proposal are to test three hypotheses, namely, 1: that the direct effect BPA on mammary gland development is mediated by ER1 and/or 2. 2: that BPA causes altered ductal morphogenesis i) by altering the composition and physical properties of the ECM and ii) by inducing adipogenesis. 3: that the different mammary gland phenotypes resulting from gestational and gestational plus lactational BPA exposure are due to alterations at the hypothalamic level. PUBLIC HEALTH RELEVANCE: Perinatal exposure to xenoestrogens, such as BPA, induce deleterious health effects such as obesity, infertility and mammary neoplasias in rodents. During the last fifty years, the prevalence of these pathologies also increased in human populations, suggesting a link between BPA exposure and these outcomes. We observed that animals exposed perinatally to low doses of BPA developed mammary precancerous lesions. The proposed study aims at characterizing the mechanisms underlying this effect. This is of utmost relevance to the evaluation of BPA, a widespread contaminant found in 92% of the tested American population, and therefore it has the potential to greatly impact public health and public health policy. Additionally, this research promises to develop a method to assess the potential breast carcinogenicity of other toxicants.

Public health relevance
Perinatal exposure to xenoestrogens, such as BPA, induce deleterious health effects such as obesity, infertility and mammary neoplasias in rodents. During the last fifty years, the prevalence of these pathologies also increased in human populations, suggesting a link between BPA exposure and these outcomes. We observed that animals exposed perinatally to low doses of BPA developed mammary precancerous lesions. The proposed study aims at characterizing the mechanisms underlying this effect. This is of utmost relevance to the evaluation of BPA, a widespread contaminant found in 92% of the tested American population, and therefore it has the potential to greatly impact public health and public health policy. Additionally, this research promises to develop a method to assess the potential breast carcinogenicity of other toxicants.